Systems genomics of complex traits

PROJECT SUMMARY
The last decade of work in genetics has shifted from examining the effects of single genes to an understanding
that most features of organisms, including human health and disease, are influenced by complex interactions
among genes and with the environment. Part of the challenge is addressing these questions is one of scale:
how can the effect of every gene in the genome be assessed in a comprehensive manner? New approaches
that take full advantage of recent developments in genomics and genome engineering are needed. We have
developed new genomic engineering and library-based barcoding approaches using the nematode
Caenorhabditis elegans that allows individual lineages to be manipulated and traced for the first time in an
animal system. We will use this method to estimate the distribution of effects for both naturally occurring and
induced mutations and multiple environments. This information will be complemented by a novel analysis of
genomic variation in the hyper-diverse species C. brenneri and mapping pleiotropic effects for oxidative stress
resistance in C. elegans. Finally, the structure of these various independent examinations of new and standing
genetic variation will be tested using genome-based simulations of the evolution of complex genetic networks.
Overall, this research uses a systems-genetics approach that integrates an understanding of natural genetic
variation within a strong functional hypothesis-testing framework to understand the function and evolution of
complex regulatory systems with critical implications for human health.

Public health relevance
PROJECT NARRATIVE Despite notable successes of identifying the genetic basis in some human diseases, most diseases are generated by complex interactions between multiple genes and the environment. New approaches using comprehensive whole-genome sequencing and genomic engineering methods in model organisms provide the opportunity to make rapid progress in understanding the underlying bases of this complexity. Using natural populations of species with extreme genetic variation provides an opportunity to identify unique regulatory elements and systems whose functional impacts would otherwise be hidden to us.